Society for Basic Urology Research 2022 Fall Meeting: Complex Cells, Systems and Regulatory Pathways In Urologic Biology

PROJECT SUMMARY: This application requests support for 20 Trainee Travel Awards for the Society for Basic
Urologic Research (SBUR) 2022 Fall Meeting entitled, “Complex cells, systems, and regulatory pathways in
urologic biology”, which will be held on November 10-13, 2022 at the JW Marriott Orlando Grande Lakes,
Orlando, FL. The SBUR Fall Research Meeting has been held annually since 1992. To the best of our
knowledge, this conference will be the only multi-day conference fully dedicated to basic urologic research in
2022. We have developed a strong program with topics that are current, cutting edge and relevant to the basic
and translational urologic research community. Invited speakers were selected to insure subject diversity and
bring together populations of investigators that will benefit from cross-talk, but may not typically interact. This
year's program includes a Trainee Symposium, three keynote lectureships, five plenary sessions and one
discussion session. The Leland W.K. Chung Lecturer, Elaine Fuchs, will discuss stem cells coping with stress
and the AUA lecturer, Larisa Rodriguez, will discuss environmental stress in the development and maintenance
of urinary symptoms, voiding dysfunction and bladder pain. Plenary session topics include 1) Cellular
communication, inflammation and immunology in urologic tissue microenvironments; 2) Cellular Identify,
Function, and Plasticity in Urologic Biology; 3) Modeling urologic biology and disease; and 4) Emerging
Pathways, Biomarkers, and Therapeutic Targets in Urologic Disease; and 5) Post-transcriptional gene regulation
in Urologic Disease. The discussion session is focused on bioinformatics and will include presentations on the
emerging practices in data acquisition and analysis. The funds requested from this application will support travel
awards for trainees and early career investigators, with emphasis on supporting women and investigators from
groups under-represented in research. The primary goals of the conference are to: 1) highlight recent findings
in the study of basic mechanisms of urologic diseases; 2) identify critical knowledge gaps in the study of urologic
diseases and stimulate approaches to address them; 3) attract leading scientists from diverse fields in benign
and malignant urology; 4) stimulate interactions between basic, translational and clinical research scientists from
diverse backgrounds to facilitate cross-disciplinary communication and collaboration; 5) cultivate active
participation of women, minorities, the disabled, trainees, and early career investigators through providing
opportunities to present their research and to create pathways for their integration into the field; 6) disseminate
and accelerate novel discoveries in urologic diseases; 7) provide career mentorship and networking opportunities
to trainees and early career investigators through the Trainee Symposium. We anticipate a meeting attendance
of >250, including SBUR members and non-members, including clinician, physician-scientist, and basic
researcher attendees, with special emphasis on early-career investigators and groups typically
underrepresented in urologic research. A robust plan is in place to enhance diversity, publicize the conference
and disseminate of the findings.

Public health relevance
PROJECT NARRATIVE The Society for Basic Urologic Research (SBUR) 2022 Fall Meeting will create a unique opportunity to highlight recent mechanistic discoveries in the study of urologic diseases; identify critical knowledge gaps and stimulate approaches to address them; attract leading scientists from diverse fields in benign and malignant urology; stimulate interactions between basic, translational and clinical research scientists; cultivate active participation of women, minorities, the disabled, trainees, and early career investigators; disseminate and accelerate novel discoveries; and provide research career mentorship and training. Attendees will include basic and clinical researchers, junior investigators, PhD and medical students, postdoctoral fellows and medical residents from diverse urologic research backgrounds. With this breadth of diversity, we anticipate that this meeting will invigorate the urologic research community, establish new collaborations and projects, and catalyze the field.